Signal Transduction Events and the Regulation of Cell Growth

Our major activities in FY2022 were to work with clinical investigators to develop new pharmacodynamic (PD) assays tailored to their clinical trials and to implement these PD assays in the clinical trials we have open in FY2022. Our specific objectives are (1) to determine if a therapy hit its target in the patient; (2) interrogate the impact of the therapy on the host, both at the systemic level, and in the tumor and tumor microenvironment; (3) work with clinical investigators to introduce new technology into their programs, including transfer of our technology intramurally, extramurally and internationally; and (4) work in collaboration with clinical and basic translational investigators to identify new drug targets and new drug mechanisms. We worked on more than 60 clinical trials in FY2022. We have focused on three main areas of biomarker analysis; (1) immune PD, (2) rare cell non-immune PD (i.e. circulating tumor cells and circulating endothelial cells), and (3) digital analyses of gene expression that can be performed on fresh, frozen, or formalin-fixed, paraffin-embedded tissue (FFPE), including digital spatial profiling of FFPE tumor, to greatly facilitate the assessment of gene expression in tumor samples. In addition, we examined systemic effects of immune- and non-immune targeted therapy on immune gene expression in peripheral blood. For the majority of the clinical trials on which we collaborate we are including immune PD as assessed by multiparameter flow cytometry. We have found and published correlations with survival in multiple clinical trials. These exploratory data have provided insight into the impact of therapy on peripheral immunity, which, as published in Nature (Wherry et al.) and PNAS (Ramalingam et al.), can provide valuable information reflective of the interaction of effector T cells and tumor and serve as a potential blood-based indicator of response to checkpoint blockade, as we published in 2019 in a collaboration with a clinical team including Drs. Karzai, Madan, Gulley and Dahut on immune profiling of castration-resistant prostate cancer patients treated with the anti-PD-L1 antibody durvalumab plus the PARP inhibitor olaparib, demonstrating evidence of CD8+ T cell reinvigoration. In 2022 we assessed all of the participants in the completed durvalumab/olaparib clinical trial, and this is currently being prepared for publication. In our immune phenotyping studies we focused on multiple populations and subpopulations of monocytes, tumor-associated macrophages, myeloid-derived suppressor cells, activated and regulatory T-cells, including expression of functional markers. In FY2022 we have performed immune subset analysis on multiple HDAC inhibitor clinical trials. Together these data have afforded us a view of the functional interplay of innate and adaptive immunity in patients at baseline and in response to treatment, which in turn, suggests combination therapies for future clinical studies to enhance antitumor activity. Drug classes we have focused on in addition to HDAC inhibitors include chaperone inhibitors, and the multikinase inhibitor cabozantinib. Previously we developed a PD assay for assessment of HDAC inhibitor activity in vivo. The NCI applied for a patent on our work, which issued in 2016. We have implemented this technology in multiple clinical trials, including 13 published clinical trials. In 2021 we published the first pediatric trial of the HDAC inhibitor entinostat in collaboration with the Pediatric Early Phase Clinical Trials Network. We also published a manuscript on the impact of entinostat plus pembrolizumab on peripheral immunity in metastatic non-small cell lung cancer. We are the National Laboratory Center of a Phase 3 ECOG-ACRIN Cancer Research Group FDA registration trial for entinostat in hormone receptor-positive advanced breast cancer, for which our PD is the only integrated biomarker. The trial was recently published and our PD assessment confirmed target inhibition in entinostat-treated patients. We are helping to bring entinostat to Japan for the treatment of women with breast cancer. Working closely with Kyowa Kirin, we completed two clinical trials of entinostat as monotherapy or in combination with exemestane. The first was published in 2022 and the second is under review. Overall, we have been working on clinical trials with 15 Branches of the NIH, three biotech companies and on two pharma trials with AstraZeneca, as well as four trials with academia (Johns Hopkins, Cleveland Clinic, Dana Farber, MIT), together encompassing Phase 1, Phase 2, and Phase 3 trials, both nationally and internationally. Working on chaperone inhibitors we previously identified Hsp40 as a new anticancer target. NIH filed for patent on this invention and the initial patent issued in FY2018 and a second patent issued in 2020. With Drs. Len Neckers of NCI and Jason Gestwicki of UCSF we are working on two DOD awards that include further development of drugs designed to hit the target we identified in my lab. We have been collaborating with Dr. Brigitte Widemann and her team on analysis of the immune infiltrate in NF1-associated tumors, including immune analysis of peripheral blood and tumor of NF1-associated plexiform neurofibromas, atypical neurofibromas, atypical neurofibromatous neoplasms of uncertain biologic potential, and malignant peripheral nerve sheath tumors. I am a key collaborator on a Childen's Oncology Group multi-institutional trial of cabozantinib from which we received samples from all over the country. In 2022 we completed analysis of peripheral immunity on these samples, and these analyses are being included in the manuscript describing the trial results. In FY2022 we have continued our collaborations with Dr. Anish Thomas on immune profiling and circulating tumor cell analyses of his small cell lung cancer (SCLC) clinical trials, including publishing of our circulating tumor cell results by Dr. Thomas in Cancer Cell in 2022. As a continuation of our work on HSP90 inhibitors we also collaborated with Dr. Thomas on a first-in-class clinical trial of an HSP90-binding molecule linked to a topoisomerase I inhibitor, for which we are doing digital gene expression using NanoString and droplet digital PCR. We identified the impact of cabozantinib on innate and adaptive immune cells in Dr. Andrea Apolo's Phase 2 trial of cabozantinib in metastatic urothelial carcinoma (Lancet Oncol. 2020). In FY2021 and 2022 in collaboration with Dr. Apolo we have continued to define the the impact of cabozantinib on systemic immunity in combination with the checkpoint inhibitors nivolumab and ipilimumab, and further analyses are in preparation. We have continued our work on circulating endothelial cells and identified an association of the severity of capillary leak syndrome with increases in apoptotic circulating endothelial cells in Dr. Christine Alewine's LMB-100 plus Nab-Paclitaxel trial of patients with advanced pancreatic adenocarcinoma and in 2022 we are working with Dr, Alewine on a phase II trial of the super-enhancer Minnelide in advanced refractory adenosquamous carcinoma of the pancreas. With Dr. Jeremy Davis in 2021 and 2022 we have been working on analysis of tissue from participants in his study of hereditary diffuse gastric cancer associated with germline inactivating variants in the CDH1 gene using the NanoString GeoMx platform for digital spatial profiling.